microRNA Profiling in the Spectrum of Kidney Tumors

Whether the miRNA profiling of the heterogeneous areas is the same or different it is not known. We studied differences and similarities of this profiling, since it may have great implications for the development of predictive biomarkers and the identification of druggable targets with improvement of combinatorial therapeutic approaches for the effective treatment of kidney cancer. Our study demonstrated intra tumoral heterogeneity of the miRNA expression profiles within the different morphologic regions of all evaluated tumors. Although different morphologic regions within a tumor did share some common miRNA dysregulations in comparison to normal kidney, each region demonstrated unique patterns of expression for some miRNAs. Identification of specific miRNA alterations could be associated with specific druggable targets leading to improvement of combinatorial therapeutic approaches for a more effective treatment of kidney cancer.